Research Education Core

(This Core is identical for all three Partnering Institutions)
The Partnership between Morehouse School of Medicine (MSM)/Tuskegee University (TU)/University of
Alabama at Birmingham O’Neal Comprehensive Cancer Center (MSM/TU/UAB OCCC) presents a distinctive
opportunity to build on our successful accomplishments in the education of future cancer research scientists
moving through our pipeline. In this U54 renewal application, we propose a seamless integration of our cancer
education programs by focusing on “hard” (structured courses/training developed through previous U54 funding)
and “soft” skills (e.g., career development roadmap, interviewing skills) needed to facilitate movement through
our pipeline into the cancer research continuum, with the goal of having an effective/skilled workforce in cancer
research. This will be accomplished through the following specific aims: Aim 1. To develop and implement
integrated cancer research education programs to link high school, undergraduate, and graduate/medical
students with postdoctoral fellows, medical residents, and Early-Stage Investigators (ESIs), and senior-level
researchers/mentors with a particular focus on cancer research. Four integrated programs will be utilized: (a)
the Granting Research Opportunities in Wellness by Creating Exciting Learning Laboratories in Science (GROW
CELLS) for high school students; (b) the Cancer Research Immersion Student Program (CRISP) for
undergraduate students; (c) the Summer Cancer Research Education Program (SCREP) for graduate and
medical students; and (d) the Cancer Research Education Program (CARE) for medical residents, postdoctoral
fellows, and ESIs. Aim 2. To link all levels of cancer research scholars with the Outreach Core to share their
research findings with community members, obtain community feedback on relevant topics for future research
(e.g., Cancer Info Cafés), and develop publications and communications for lay audiences (e.g., blogs or posts
on social media, YouTube videos, policy briefs). Aim 3. To implement a mixed-method, triangulated evaluation
of the proposed research education activities across the pipeline. These efforts will increase the recruitment and
retention of scholars/students in science, specifically in cancer research, which are congruent with the goals of
NIH.

Public health relevance
The Research Education Core will expand structured training and career development opportunities to individuals from high school through faculty levels, fostering entry into the cancer research workforce. By engaging the participants from rural and urban communities in the Southeast, this effort supports a more regionally relevant and skilled workforce to help reduce the cancer burden.